Investigating NPEPPS-mediated feedback between bladder cancer cells and peripheral neurons as a mechanism of cisplatin resistance

PROJECT SUMMARY – Parent R01 CA268055
Cisplatin (Cis)-based Neoadjuvant chemotherapy (NAC) is the standard of care prior to cystectomy, for patients
with muscle-invasive bladder cancer (MIBC). Up to 30% of patients respond and show no residual tumor at
cystectomy with >80% survival, but “non responders” have <30% chance of surviving 5 years. Thus, improving
the effectiveness of Cis-based NAC will greatly improve outcomes in BC. Through whole-genome CRISPR-Cas9
synthetic lethal screens in Cis-resistant human BC cell lines, we discovered NPEPPS as a novel and druggable
target whose expression determines sensitivity to Cis. NPEPPS was the only one of 13 M1 aminopeptidases
found to be synthetic lethal with Cis. Depletion of NPEPPS enhanced Cis therapy and reduced growth in animal
models. To find how NPEPPS drives these two phenotypes, we used mass spectrometry (MS) to identify the
proteins that are in complex with NPEPPS in BC cells. We found NPEPPS in complex with subunits (LRRC8A-
E) of the volume regulated anion channel (VRAC), a recently identified mechanism of platinum (Pt) cellular
import. In BC cells, LRRC8A/D depletion increases resistance to both cisplatin and carboplatin, while NPEPPS
depletion had the opposite effect. Supporting a role in human BC growth, NPEPPS expression is associated with
poor patient outcome regardless of chemotherapy use. Leveraging our MS results, we developed an approach
to prioritize candidate genes found in complex with NPEPPS that most likely affect growth, are associated with
aggressive disease, and are prognostic markers.
Thus, we propose the Guiding Hypothesis that NPEPPS
drives Pt resistance and tumor growth in BC by inhibiting VRAC activity and interacting with genes regulating
cell proliferation respectively. Specific Aims test this hypothesis with the Objective to lay the foundation for
novel approaches to improve the outcomes for BC patients.
In Aim 1 we
will test the hypothesis that NPEPPS
aminopeptidase activity is required for Pt resistance and growth using enzymatically dead NPEPPS mutants in
vitro and in vivo. Next, we evaluate our top candidate gene CHD2, a chromatin regulator and putative tumor
suppressor for its role in NPEPPS-driven tumor growth and the dependency of this role on NPEPPS enzymatic
activity. In Aim 2 we will determine the role of LRRC8A/D in NPEPPS-mediated Pt resistance. We have used
molecular modeling to identify residues on NPEPPS that interact with LRRC8A/D. Site-directed mutagenesis of
these residues will test the hypothesis that direct interaction of NPEPPS with LRRC8A/D reduces the ability of
VRACs to properly function and contributes to NPEPPS-mediated Pt resistance in vitro and in vivo. To establish
the preclinical rationale for the effect of novel, anti-neoplastic agents that circumvent Pt resistance, Aim 3 will
test the hypothesis that Tosedostat (Tose), a clinically well-tolerated aminopeptidase inhibitor, enhances the
sensitivity of BC to Pt, and NPEPPS expression is required for this. The impact of Tose on BC cells ± NPEPPS
expression will be examined for growth, Pt sensitivity and import in vivo in human BC models of localized and
metastatic disease. Organoids derived from patient tumors before Cis-based NAC, will be tested with Pt ± Tose.

Public health relevance
PROJECT NARRATIVE – Parent RO1 CA268055 Cisplatin-based combination chemotherapy is the standard-of-care treatment for muscle invasive bladder cancer but 70% of patients do not respond. We discovered a novel mechanism by which puromycin-sensitive aminopeptidase, NPEPPS, is upregulated, and we have strong evidence supporting its interaction with volume- regulated anion channels (VRACs) to block import of cisplatin and other platins into cancer cells. The focus of this proposal is to characterize this novel mechanism and evaluate pharmacological inhibition of NPEPPS in combination with platin drugs in preclinical models with the objective of eventually improving patient outcomes.